Neutrophil derived proteinases abolish the IFNG signature in NSCLC

ABSTRACT
Although immune checkpoint inhibitor (ICI) therapy has been a tremendous clinical success, just ~20% of non-
small cell lung cancer (NSCLC) patients respond to anti-PD1/PDL1 therapy. The two major factors predictive of
favorable treatment response to ICI therapy are the presence of the IFNG signature and evidence of CD8+ T cell
infiltration into malignant tumor. Work from our group has shown that neutrophil infiltrated non-small cell lung
cancers do not display the IFNG signature, do not display CD8+ infiltration into malignant tumor, and do not
respond to ICI treatment. Our hypothesis to explain these observations is that tumor-associated neutrophils
release proteinases that degrade key cytokines (IFNG), chemokines (CXCL-9, -10, -11) and a chemokine
receptor (CXCR3) that destroys the IFNG mediated chemotactic gradient that facilitates T cell infiltration into
tumors. The proposed studies will demonstrate that a number of key neutrophil-derived proteinases are capable
of degrading T cell recruiting chemokines and CXCR3 and identify the novel cleavage products resulting from
these events. The functional consequences of these proteolytic events will be demonstrated in novel multicellular
tumor-in-chip systems and in state-of-the art mouse models of lung cancer. Lastly, we will employ a combined
fluorescent in-situ hybridization (FISH) and multiplexed immunohistochemistry (M-IHC) panel to study the
relationship between CXCL9 expressing tumor cells, infiltrating CD8+CXCR3+ T cells, and TAN and determine
the impact that these measures have on ICI treatment outcomes in NSCLC patients.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer deaths worldwide, accounting for ~130,000 lives annually in the US alone. We have generated data from a large cohort of lung cancer patients showing that neutrophils inversely correlate with CD4+ and CD8+ lymphocyte content within lung tumors. The purpose of this project is to demonstrate that tumor-associated neutrophils limit the ability of T cells to infiltrate into the malignant portions of tumors. Successful completion of the proposed studies should identify a therapeutic strategy with which to improve T cell infiltration into cancers that would improve response rates to immune based therapies.